Visual Neuroscience Advanced Research Training Course

Abstract
We request support from the NIH Brain Initiative for a two-week Advanced Research Training course in Visual
Neuroscience (VN) at the Marine Biological Laboratory (MBL) in Woods Hole, MA. Vision is our most precious
and important sense, with more than 50% of the cerebral cortex involved in processing information from our
eyes. Vision is the most widely studied sensory modality, investigated by research laboratories around the
world who seek to understand normal visual function and vision disorders. Driving these efforts are new
technologies for visualizing and identifying different types of neurons, mapping neural connectivity, and
measuring and manipulating neural activity at different scales to determine the neural basis of visual
perception. While most graduate students and postdocs encounter some advanced technologies, most
institutions do not have an organized lab course that covers the broad range of modern methods in visual
neuroscience. Our goal is to establish a new intensive summer course that will jump-start lab proficiency and
solidify the learning of fundamental concepts in visual neuroscience. Our specific aims are to: 1) Train students
in the fundamental concepts of visual neuroscience, through lectures given by faculty who are thought leaders
in their fields. Topics will range from phototransduction, to information processing, to transformation of neural
activity to visual control of behavior. 2) Train students in modern methods for understanding the visual system,
including large-scale electron microscopic analysis of the visual system connectome, large-scale
multielectrode recording of spike activity, large-scale functional imaging of assemblies of neurons in the visual
system with activity-dependent fluorescent indicators, and large-scale transcriptomic analysis to determine the
molecular identity of individual cells. The course will take a comparative approach, utilizing various model
systems including an invertebrate (octopus), a cold-blooded vertebrate (zebrafish), and a mammal (mouse). 3)
To build community between students and faculty who study the visual system across multiple levels of
organization. The MBL is a fertile environment for scientific innovation and communication and the high faculty
to student ratio is ideal for building professional relationships that will promote students’ success throughout
their careers. 4) To enhance the diversity of both teaching faculty and VN students. Faculty from diverse
backgrounds will enrich the learning experience, in part by serving as excellent role models for attracting more
diverse student applicants. The course resonates with at least 4 priority areas targeted by the NIH BRAIN
Initiative: 1) identification and characterization of distinct neuronal cell types, 2) investigation of circuit
connections that map the visual world, 3) recording the dynamics of neuronal signaling in the visual system to
better understand representations of changing visual stimuli, 4) linking spatiotemporal patterns of brain activity
with visually-evoked behavior to elucidate mechanisms of visual perception.

Public health relevance
Narrative This project is to support an Advanced Research Training course in Visual Neuroscience at the Marine Biological Laboratory in Woods Hole, MA. The goals of the course are to prepare the next generation of a highly diverse group of visual neuroscientists with a broad understanding of the concepts, methods, model systems, and analytical tools required for understanding how the visual system captures, encodes, and processes information, leading to visual perception and behavior. We expect the Visual Neuroscience course will be a transformative experience for trainees who enroll, inspiring new directions in research and dramatically improving future success in their research careers.